Longitudinal Academic Performance in Children with a History of Neonatal Abstinence Syndrome

Project Summary/Abstract
The objectives of this project are to more thoroughly understand the relationship between neonatal
abstinence syndrome (NAS) and longitudinal academic performance. NAS is a withdrawal condition due to in
utero drug exposure, most commonly opioids. The syndrome affects more than 32,000 newborns annually in
the U.S., and its incidence continues to rise. Researchers report poorer development in toddler and preschool
years, higher rates of inattention and behavioral problems, and worse and deteriorating school performance in
children with a history of NAS, indicating the effects of NAS may last well beyond the newborn period.
However, these existing studies do not sufficiently account for the complex interaction of biologic, health, and
socioenvironmental influences on childhood development. Thus, the relationship between NAS and long-term
neurodevelopment and academic achievement remains largely unknown. As school achievement is directly
associated with adult productivity and negatively correlated with participation in crime, a better understanding
of NAS and academic performance is urgently needed to optimize outcomes across a lifetime.
This proposal aims to assess the independent relationship between NAS, NAS severity, NAS treatment, in
utero drug exposure and longitudinal academic performance after controlling for relevant biologic, health, and
socioenvironmental variables; to explore the moderator effects of early community and school resource
support on NAS; and to learn how families’ school experiences may explain childhood academic performance.
The former aims will be accomplished using an inclusive, uniquely-integrated South Carolinian data
warehouse. With this data system, a child with a diagnosis of NAS can be linked with his/her mother, and the
dyad can be followed so that a broad range of childhood outcomes can be examined in the context of relevant,
influential factors. In addition, through qualitative interviews with parents and guardians of children with a
history of NAS followed at a Pennsylvania academic medical center, the project will 1) explore if and how
caregivers’ experiences regarding early community and school resource support are related to childhood
academic performance and 2) analyze themes that emerge around barriers and facilitators of academic
achievement in children with NAS.
Under this career development award, the applicant receives training in methodology of data-driven, public
health studies and patient-oriented, clinical research design; epidemiology, mixed methodologies, community
health, and applying public health principles to clinical practice; and moving research to policy. Successful
completion of the project will not only provide data to serve as the foundation for future studies evaluating NAS
outcomes and treatment, but, in addition to her training and mentorship plan, will prepare the applicant to
become an independent physician-scientist able to conduct clinical trials aimed at improving outcomes of
children affected by NAS.

Public health relevance
Project Narrative Neonatal abstinence syndrome (NAS), a withdrawal condition due to in utero drug exposure, affects over 32,000 newborns in the U.S annually, and its incidence continues to grow concurrent with the opioid crisis. The association between NAS and long-term neurodevelopment is largely unknown. This project will examine the relationship between NAS and longitudinal academic performance and explore targets for future interventions aimed at improving educational outcomes in children with a history of NAS.